Enhancing AI-based Speech Therapy through Acoustic-Derived Articulatory Feedback

Project Summary/Abstract
This proposal aims to leverage advances in artificial intelligence (AI) to develop clinically impactful tools that
can support progress in speech therapy for children with Speech Sound Disorder (SSD) while alleviating the
pressing issue of overburdened speech language pathologist (SLP) caseloads [5]. SSD affects a significant
portion of school-aged children [1, 13], leading to social and emotional challenges that can persist into
adolescence and adulthood [14, 16, 17]. This project aligns with the NIH health-related mission by focusing on
improving access to effective speech therapy, thereby enhancing the quality of life for individuals with SSD.
Research suggests roughly 5,000 accurate speech productions are necessary for speech sound
generalization [4], motivating the development of AI systems to supplement therapy. However, a critical
challenge in automating therapy is providing accurate qualitative feedback, especially for complex sounds like
the American English rhotic /ɹ/. Ultrasound biofeedback has shown promise in therapy [24], but cost and
training barriers limit its adoption. The research design involves using state-of-the-art machine learning
algorithms to analyze a multimodal corpus of children's speech collected in our team’s previous research.
Acoustic and ultrasound data will be processed and segmented to extract relevant features, which will then be
used to train and evaluate the performance of the machine learning models. The project will incorporate
innovative techniques such as cross-modal embedding and retrieval [11] to integrate information from multiple
modalities and improve the accuracy of pattern recognition.
More specifically, the first aim focuses on training an acoustic classifier to identify tongue shapes within
the class of perceptually accurate /ɹ/ productions using acoustic data. Ground truth labels were obtained from
previous human coding of articulatory patterns [9] and will be supplemented with additional labeling.
Supervised machine learning methods will be employed to differentiate between tongue shapes, aiming for
high precision and recall. The second aim focuses on utilizing semi-supervised machine learning methods to
distinguish clinically relevant acoustic-articulatory patterns within both accurate and inaccurate /ɹ/ productions.
Ground truth labels provided by certified SLPs will inform the training of models, which will be designed with
cross-modal embedding to recognize patterns with high precision and recall in a high-dimensional multimodal
dataset comprising audio and ultrasound data [11].
The study anticipates developing classifiers suitable for differentiating tongue shapes within accurate
and inaccurate /ɹ/ productions, with potential applications in enhancing clinician cueing and providing at-home
practice for children with SSD. The long-term goal is to integrate these classifiers into freely available clinical
speech software which will provide accurate customized articulatory feedback for /ɹ/ as a first step, with the
potential to expand to other speech sounds in the future.

Public health relevance
Project Narrative Children with residual speech sound disorder experience barriers to social and academic participation that may manifest as life-long personal and professional obstacles if their speech deviations are not remediated in a timely manner [14, 22]. The current proposed research will meet a public health need by developing and testing machine learning methods to recognize a speaker’s articulatory pattern for perceptually accurate and inaccurate American English /ɹ/ from the corresponding acoustic signal. This study has significant potential for long-term clinical impact through incorporating customized automated articulatory feedback into a freely accessible application for visual-acoustic biofeedback software which will support more effective at-home practice, thereby filling in gaps in service delivery and expanding access for underserved populations [3, 5].